Steroid Treatment for Severe Acute Respiratory Infection (STAR) trial

Multicenter, parallel-group, blinded, randomized clinical trial comparing
the administration of systemic corticosteroids at a dose equivalent to 40
mg of prednisolone per day for 7 days vs no corticosteroid administration
among adults hospitalized with severe acute respiratory infection and
hypoxemia. Adult (age ≥ 18 years) participants hospitalized with severe acute
respiratory infection and hypoxemia. Participants will be excluded if they
have been hospitalized for >72 hours, have a primary etiology of
hypoxemia other than respiratory infection, have a known allergy to
corticosteroids, have an established indication for systemic corticosteroids
(e.g., acute SARS-CoV-2) or an established contraindication to systemic
corticosteroids (e.g., disseminated fungal infection), or if clinicians have
determined that systemic corticosteroids are required or contraindicated
for the optimal care of the patient.